HIV Center for Clinical and Behavioral Studies

Even in the face of new prevention and treatment advances, the HIV/AIDS epidemic remains a critical public health emergency. This renewal of the HIV Center for Clinical and Behavioral Studies (HIV Center) at New York State Psychiatric Institute (NYSPI) is based on the premise that biomedical advances for HIV prevention and treatment will not reach their full potential without rigorous behavioral, social science, and translational research to optimize uptake, adherence, and enhanced implementation and scale-up. We will build on our interdisciplinary HIV research history– leveraging emerging knowledge bases and new and continuing community, scientific, and health department partnerships-- to actualize the power of biomedical advances in HIV prevention and care for all. Our Center evolves with each renewal – refocusing and bringing in new collaborators to meet current HIV/AIDS scientific and public health challenges. In the next five years, guided by the theme, Reducing HIV and Mental Health Challenges to End the HIV Epidemic (EHE), we will bring together an expanding group of investigators and clinical and community partners working at the forefront of HIV behavioral, social, biomedical, and implementation sciences. The renewed HIV Center will provide a rigorous, theoretically grounded behavioral and social science foundation that catalyzes and supports robust, innovative HIV research to maximize the benefit of biomedical advances for affected populations by addressing the following three Specific Aims: (1) To advance our understanding of individual, social, and systemic drivers of the HIV epidemic including mental health and social determinants of health and development of intervention and implementation science research to achieve EHE goals; (2) To promote translation of clinical and research findings to prevention and care settings for maximum public health impact; and (3) To expand the cadre of HIV researchers by engaging a pipeline of emerging investigators. Our Cores ensure methodological and theoretical rigor, rapidly respond to new trends in the epidemic, support critical research-practice partnerships, and train new scientists. Three Research Cores will complement the Administrative and Development Cores: (1) Statistics, Data Science, and Data Management Core, promoting state-of-the-art approaches to study design, data science, and data analytic methods; (2) Clinical Translation Core, integrating biomedical and behavioral research for implementation in real-world settings; and (3) Health Equity Core, focusing on HIV challenges mediated by mental health problems including substance misuse and social determinants of health.

Public health relevance
The HIV Center will advance the goals of the US National HIV/AIDS Strategy and the NIH to End the HIV/AIDS Epidemic (EHE), by stimulating and supporting research that targets the communities most affected by social, behavioral, and mental health challenges. We will build and expand on our history of interdisciplinary HIV research – leveraging emerging knowledge bases and new and continuing community, scientific, and health department partnerships --to promote research focusing on individual, social, and systemic barriers to actualizing the power of biomedical advances in HIV prevention and care. We will identify and rapidly respond to new trends in viral epidemics supporting research-practice partnerships that foster innovation, train the next generation of scientific leaders, increase understanding of drivers of the epidemic, and foster translation of clinical and research findings to prevention and care settings for maximum public health impact.